Promoting Protein Trafficking with 4-phenylbutyrate to Treat Genetic Epilepsy

Despite the discovery of hundreds of genetic mutations associated with epilepsy and neurodevelopmental
comorbidities – including autism and intellectual disability (ID) – no effective treatments are currently available.
Our recent work has identified the primary common mechanisms across mutations at a large scale in astrocytes
and inhibitory neurons that express the GABA transporter 1 (GAT-1) encoding SLC6A1. Preliminary findings
suggest 4-phenylbutyrate (PBA), a previously FDA-approved chaperone inducer for pediatric use, displays a
mechanism-based rescue in those mutations. Specifically, PBA appears to repair mildly misfolded proteins and
increase membrane expression of the wildtype allele across all tested mutations. Moreover, our success has
prompted a pilot trial with very promising results. This study aims to fully characterize the effect and detailed
mechanisms of PBA rescue. Our central hypothesis states that protein misfolding and impaired trafficking
are standard mechanisms for SLC6A1 mutations, which display rescue potential through
pharmacological intervention by restoring effective protein activity. As a part of our research, our lab has
developed highly relevant preclinical model systems, including a plasmid library of SLC6A1 mutations, mutation-
bearing patient cell lines, and knockin mouse models. Future studies focused on these model systems will
provide critical insights into disease mechanisms with high potential of translating the findings to treatment.
Moving forward, our lab aims to (1) evaluate the effect of PBA on restoring GAT-1 function in vitro for 20 patient
mutations, (2) gauge the effect of PBA on restoring GAT-1 function in vivo in Slc6a1 mutation knockin mice, and
(3) elucidate the underlying mechanism of PBA rescue on GAT-1 functioning to establish a foundation for novel
treatment approaches. Research design and methods. We will employ a plasmid library containing >50
SLC6A1 mutations identified from patients across a wide spectrum of disease phenotypes, two knockin mice,
and two lines of patient induced pluripotent stem cells (iPSCs) derived neurons and astrocytes to determine the
impact of PBA on the mutant GAT-1 trafficking and function. We will utilize a multidisciplinary approach, including
in vivo microdialysis, to determine the dynamic interplay of GAT-1 inhibition, GABA levels, and seizures in
knockin mice. All patients carrying SLC6A1 mutations are heterozygous, which suggests there is benefit in either
boosting the remaining wildtype allele or rescuing the mutant copy or both. In either case, the overall GABA
uptake activity should be improved in patients. The large-scale study will provide us a broad view of the impact
of PBA. In contrast, the in-depth investigation of mice and patient-derived cells will provide critical insights into
PBA's rescue mechanism in partial and complete loss-of-function mutations. We propose to test this hypothesis
in vitro and in vivo with high-throughput assays and cutting-edge new techniques in iPSCs and mutation knockin
mice. Our goal is to identify a novel treatment target for genetic epilepsy using SLC6A1 as example. We believe
the impact of this study is broad as it can be scaled up for many genetic epilepsy syndromes and others.

Public health relevance
Narrative (public health related) Seizure disorders (epilepsies) are very common and some children suffering from seizures also have autism and intellectual disabilities. In this proposal, we will use mutation-bearing mouse and cell models, including patient- derived cells, to in-depth study the disease mechanisms and test a novel rescue option via repairing impaired protein trafficking. Our goal is to design the most effective treatment option based on the specific patho- mechanisms and correct the problem at the root level.